Core A: Leadership and Administrative Core

PROJECT SUMMARY/ABSTRACT
The Leadership and Administrative Core (LAC) will serve to integrate and enhance the research conducted by
the Pacific Northwest Prostate SPORE Projects and Cores – as well as faculty supported by the Career
Enhancement and Developmental Research Programs – through the application of general administrative
support and the facilitation of communication and data dissemination.
The Core will also provide formal links between the following entities:
(1) All investigators comprising the Pacific Northwest (PNW) SPORE in prostate cancer;
(2) Advisory Panels (e.g., External Advisory Board [EAB], Internal Advisory Board [IAB], etc.);
(3) The institutions (e.g., FHCRC and other SPORE participatory sites) with laboratories and clinical
facilities wherein occur the research and education components of the SPORE; and
(4) Representatives of the National Cancer Institute (NCI).
This Leadership and Administrative Core has the following Specific Aims:
Specific Aim 1: To provide the organizational structure, based on a group of interacting committees, for
supporting and evaluating the key objectives of the PNW SPORE.
Specific Aim 2: To provide oversight of all SPORE activities involving the independent research projects, the
Career Enhancement Program (CEP), the Developmental Research Program (DRP), the
shared resource Cores, and the parent institutions.
Specific Aim 3: To organize and coordinate forums for interactions of the Executive Committee, Internal
Advisory Board, and External Advisory Board.
Specific Aim 4: To provide efficient and effective fiscal management of SPORE grant funds.
Specific Aim 5: To communicate and consult with the NCI Project Officer(s) and staff in the preparation of
required progress reports, publications lists, and regulatory documents.
Specific Aim 6: To develop and maintain virtual mechanisms that efficiently facilitate multi-institutional, intra-
and inter-SPORE interactions.

Public health relevance
PROJECT NARRATIVE The ongoing, successful functioning of the PNW Prostate Cancer SPORE is highly-dependent upon the effective and efficient operations provided by the Leadership and Administrative Core. The Core is vital for carrying out the overall scientific and translational SPORE mission and will continue to be the hub for SPORE-related management, education, and communication within and across the four SPORE institutions.